A molecular toolkit for the production of tyrosine phosphorylated proteins

Project Summary Tyrosine phosphorylation can regulate protein function, and this is a cornerstone of cell signaling networks. Ty- rosine phosphorylation often becomes dysregulated in cancer and therefore, understanding the effect of phos- phorylation on protein function will be paramount to identifying therapeutic interventions in cancer. Unfortunately, an important tool in the basic research of phosphorylation — testing the effect of protein phosphorylation by com- paring the function of the phosphorylated form with an unphosphorylated form of the protein in in vitro assays — is signiﬁcantly hindered by our limited knowledge in how to make a phosphorylated protein. This project seeks to build a molecular technology, inspired by previous observations of biochemistry in cell networks, to overcome this requirement and improve the pace of basic research. The goal of this research is to build a fast, accessible and inexpensive method for producing phosphorylated and soluble proteins in a bacterial system. The goals will be achieved by: development of a molecular toolkit for the enhancement and control of precise phosphorylation on protein substrates using secondary kinase-substrate targeting approaches, testing the toolkit on a set of sub- strates, and comparing the outcome with current technologies. It is anticipated that this technology will be less expensive, more physiologically-relevant, and capable of producing a larger variety of phosphorylated forms of proteins than current molecular approaches to studying the effect of protein phosphorylation.

Public health relevance
Project Narrative In accordance with the purpose of the NCI RFA-CA-16-001, this project will accelerate basic cancer research through the development of a molecular technology, which will enable rapid advances in the understanding of tyrosine phosphorylation – a process consistently dysregulated in human cancers.